Cellular and Molecular Mechanisms of Brain Aging

Age is the greatest risk factor for most causes of morbidity in developed nations. Research into the cellular and
molecular processes that underlie aging and age-related diseases is essential if significant improvements in
healthy aging are to be accomplished, including insights for clinical practice and for novel treatment development.
The Science Research Conference (SRC) “Cellular and Molecular Mechanisms of Brain Aging” is a partnership
between the Federation of American Societies for Experimental Biology (FASEB) and the American Aging
Association (AGE) and is designed to provide a forum for investigators to present and discuss the latest in brain
aging research. While both AGE and FASEB promote dissemination of biomedical research results, AGE works
specifically to promote research on the fundamental processes of biological aging with the goals of increasing
the functional life of humans, inform the public of progress in aging research, and expand knowledge of
biogerontology among medical professionals and the lay public. Along with disseminating cutting-edge research
on the mechanisms contributing to brain aging, additional goals of this FASEB/AGE SRC are to provide a venue
for career advancement for early investigators and trainees, and to foster growth of the neurobiology of aging
research community. This meeting is unique in that it focuses on the neurobiology of aging as distinct from being
focused on age-related neurodegenerative disease, includes diverse expertise on a host of emerging topics and
technologies in neurobiology, and includes key features of translational and human research, providing a
blueprint for new investigators to forge translational avenues.
We are requesting funds to support the “Cellular and Molecular Mechanisms of Brain Aging” SRC that will take
place on September 15-19, 2024, in Niagara Falls, New York. There are three specific aims. Aim 1: Bring
together thought leaders/researchers in the area of cellular and molecular mechanisms of brain aging to advance
the field and accelerate the pace of discovery; Aim 2: Foster career development in the field of neurobiology of
aging, supporting recruitment of new ideas and new innovation in this growing research discipline; and Aim 3:
Raise public awareness of and communicate the value of neurobiology of aging research to a broader audience.
To accomplish these aims, we have designed a program that features (i) new ideas and emerging leaders in
neurobiology, (ii) a breadth of topics spanning multiple disciplines that capture the state-of-the-art in neurobiology
of aging research, (iii) contributions from Early Career Investigators (ECI) (each session includes at least one
ECI and one trainee talk selected from abstracts), (iv) diversity among the invited and selected speakers, and
(v) specific outreach to underrepresented communities to enhance diversity at the conference. This unique
conference will serve as a critical venue for exchanging ideas, fostering new collaborations, and developing the
next generation of researchers. In addition, this meeting works towards the goal of translating knowledge into
therapeutic interventions that promote brain health even into advanced age.

Public health relevance
Narrative This proposal requests support for early career inves4gators and trainees to par4cipate in the Cellular and Molecular Mechanisms of Brain Aging conference to be held in Niagara Falls, NY September 15-19, 2024. The goals of this inter-disciplinary mee4ng are to bring together inves4gators to advance the ﬁeld of neurobiology of aging, to foster career development, and to raise public awareness of this cri4cal area of aging research.